Structure and Relations of Protein and Nucleic Acids

Summary/Abstract for requested administrative supplement to GM-15792-56.
With this administrative supplement proposal to our current NIGMS grant GM-15792-56 we seek funds to
purchase a two-photon excitation single molecule fluorescence microscope to extend and enhance our DNA
replication studies. A substantial part of our ongoing research efforts are focused on achieving a detailed
mechanistic understanding of the sub-assemblies of the T4 DNA replication complex by applying spectroscopic
methods that site-specifically position fluorescent and optically active probes into the DNA framework of the
complex. We use these labeled constructs to spectroscopically monitor – both with bulk (ensemble) solution
measurements and at the single-molecule level – functionally significant conformational changes that occur at
and near the local probe positions.
The two-photon excitation single molecule fluorescence (2PE-SMF) method developed by the Marcus lab can
determine the relative stabilities of conformational species and monitor the kinetics of conformational transitions.
We have pursued two different fluorescent probe-labeling strategies for our studies on DNA and protein-DNA
interactions. We use pairs of spectrally visible iCy3 dyes placed (internally) within the DNA backbones at defined
positions to study the structure and dynamics of local DNA backbone conformations, while pairs of fluorescent
6-MI base analogues, which have been substituted for natural guanine DNA bases, are used to obtain
complementary information about the structure and dynamics of the bases and base-pairs at defined sites within
our model DNA constructs.
We have thus far achieved considerable success in performing bulk solution and single-molecule experiments
using the visible iCy3-substituted DNA constructs. However, the complementary experiments with 6-MI have
proceeded more slowly due to technical limitations that make spectroscopic studies in the ultraviolet regime
challenging. Recently, we made considerable advancements in performing pulsed laser experiments on 6-MI in
bulk solution using a two-photon excitation strategy that uses a dedicated laser that we purchased and
assembled with an NIH Administrative supplement in 2018. Unfortunately, it is not yet possible to extend these
experiments to the kinetics of local base conformational changes, as we have done for our visible iCy3 backbone
probes. This is due to the absence of a dedicated single-molecule fluorescence microscope that can be
integrated with our 2PE laser, which uses 680 nm pulsed light. Our current single-molecule systems are
optimized for the visible iCy3 dyes that use 532 nm light. The existing instruments cannot be modified on a
routine basis to perform the necessary complementary experiments on 6-MI. To pursue these two sets of
experiments in parallel we herewith request funds to purchase an additional instrument that will be optimized to
perform 2PE-SMF experiments on 6-MI-substituted DNA constructs. These experiments will greatly expand our
ability to understand the DNA conformational changes that are central to regulating DNA replication.

Public health relevance
Narrative for administrative supplement request for GM-15792-56 We request funds to enable the purchase of a two-photon excitation single-molecule fluorescence microscope that will permit us to use fluorescent base analogues with advanced spectroscopic techniques to study DNA structure and dynamics within functional protein-DNA complexes. These complexes operate as ‘macromolecular machines’ within living cells to faithfully replicate (copy) the DNA genome to form the genetic material of the daughter cells, to transcribe and process specific messenger RNA sequences, to permit ‘expression’ of the defined genes and to direct the synthesis of specific required proteins at various stages of development. The requested supplementary funds will permit us to continue and expand a program of research that uses the methods of physics and chemistry to understand the molecular processes that are involved in the function and regulation of these machines, in part because understanding these central processes in molecular detail will help in the development of specific tools to control diseases of anomalous gene expression and development, including various forms of cancer and related genetic diseases.